Chemistry-Biology Interface Training Grant

Project Abstract
This proposal requests continuing support for a Vanderbilt Chemistry-Biology Interface (V-CBI)
Training Program at Vanderbilt University. Thirty-six faculty preceptors from eight Ph.D.
granting departments and programs in the Colleges of Arts and Sciences and Basic Sciences
will serve as mentors for the Program. Signicant training and education in biology will be
provided to students receiving in-depth training in synthetic/mechanistic and analytical
chemistry and significant training and education in the chemistry will be provided to students
receiving in-depth training in the biological sciences. Highlights of the training program include
a common chemical biology 15 week course, elective courses for cross education, a course in
experimental design and research reproducibility, student organized research and professional
development seminars, a semnar series in chemical biology, an annual research symposium,
participation in an annual career development conference and a unique experience in
laboratory experimental design and technical training for application in an undergraduate
research laboratory. Students will receive in-depth education and training in a core discipline
and cross training in complementary fields to allow them to work effectively in multidisciplinary
research environment. Support for ten trainees is requested. Trainees will obtain Ph.D.
degrees working with preceptors in the Departments of Biochemistry (10 preceptors),
Chemistry (10 preceptors), Cell and Developmental Biology (2 preceptors), Pathology and
Microbiology (3 preceptor), Pharmacology (5 preceptors) and Radiology and Radiological
Science (1 preceptor).

Public health relevance
Project Narrative The trainees participating in the CBI training program are engaged in a number of NIH-supported projects that employ techniques, understanding and tools of chemistry to study a variety of biomedical problems with relevance to the study of human biology, health and therapeutic agent development.